Neighborhoods, Mental Health, and the Prevention of Opioid Overdose: A Mixed Methods Approach

PROJECT SUMMARY/ABSTRACT
Increasing opioid use in the U.S. has led to a dramatic increase in opioid-related fatal and non-fatal overdoses
(OD), and adults with mental health disorders, including anxiety and mood disorders, are significantly more
likely to use nonprescription opioids. Mental health and associated drug use are directly and significantly
impacted by the neighborhood environment, but few studies have examined the impact of modifiable
neighborhood features on OD risk. The broad objective of this study is to investigate modifiable neighborhood
factors which impact mental health and which may contribute to opioid OD. The proposed research will achieve
the following interconnected specific aims using mixed quantitative/qualitative approaches with fatal OD data
from New York City, Chicago, and Seattle and original in-depth interviews with people who use drugs: (1)
investigate the associations between modifiable physical and social neighborhood factors and opioid OD; (2)
examine key mental health indicators as mediators of the relationship between modifiable neighborhood factors
and opioid OD; (3) comparatively investigate the associations between modifiable neighborhood factors, mental
health indicators, and opioid OD, comparing the locations where people who use opioids lived versus the
locations where they overdosed. In-depth interviews with people who use drugs will provide context for
quantitative results, identifying mechanisms by which neighborhood impacts drug using and associated OD risk
and informing novel strategies for OD prevention. This K01 mentored research scientist development proposal
will provide the training and expertise needed to transition to research independence in drug use research. Five
specific training areas will be incorporated to carry out these research goals: (1) obtain advanced skills in
structural equation modeling and Bayesian modeling methods, and causal inference theory and methods; (2)
develop expertise in mixed quantitative and qualitative methods research theory, design, and analysis, and build
capacity in collecting and analyzing qualitative data; (3) develop subject matter expertise in psychiatric
epidemiology and associated drug use risk factors, in particular, major depression, general anxiety disorders,
and diagnostic criteria for psychiatric disorders; (4) obtain additional training in the ethical conduct of research
among marginalized and stigmatized populations; (5) build professional skills for a successful research career as
an independent scientist leading multidisciplinary teams to build new knowledge and address major challenges
in drug use and abuse. These training goals will be achieved through a combination of didactic courses,
specialized workshops, hands-on research, and mentoring from an interdisciplinary team of experts. This
research and training will lead to a subsequent R01 proposal that formally tests implementation strategies and
effectiveness of neighborhood-level interventions for OD prevention.

Public health relevance
PROJECT NARRATIVE Strategies to prevent opioid overdose which impact large groups of opioid users at multiple levels of influence are acutely needed. The broad objective of this K01 proposal is to investigate modifiable neighborhood factors which impact opioid misuse and mental health and which may contribute to opioid overdose using a mix of both quantitative and qualitative methods. The proposed research and training will lead to a subsequent R01 proposal that formally tests implementation strategies and effectiveness of neighborhood-level interventions for overdose prevention.